Waiting for a better future: Deciding when to "cash in" when outcomes are continu

DESCRIPTION (provided by applicant): The proposed research extends prior work on impulsive behavior and delay discounting. When choosing among options with different delays to their outcomes, people and other animals devalue later outcomes relative to sooner ones. Delay discounting is thought to underlie much deleterious behavior. People eat highly caloric desserts, charge trivial goods and services, take illicit drugs, smoke, or drink excessively without regard for the long term consequences of those momentary pleasures. People presumably make these decisions because the value of the delayed consequences is discounted. Improving our understanding of the basic principles of behavior underlying the socially significant decisions may improve our ability to address those problems. The present application extends prior work by assessing delay discounting in a dynamic environment where reward amount grows continuously with wait time. Historically, delay discounting has been most frequently studied using discrete trial choice procedures. Subjects typically make a series of choices between smaller sooner and larger later rewards (e.g., "Would you prefer $100 now or $150 in a month?" for people or 2 pellets immediately vs. 4 pellets at a 10 second delay for rats). Although the utility of these procedures is unquestioned, they represent but one type of relationship between behavior and proximal and distal outcomes. Thus, we hope to extend the delay discounting account of impulsive behavior to an environment where the relationship between action and outcome is more continuous and dynamic in real time. Humans will perform within the context of a 3-D immersive video game in which firing a weapon sooner will produce less damage than firing it later, whereas rats will be trained to hold down a lever to increase available food amounts upon its release. That is, we will assess when the subject will "cash in" and take the immediate reward rather than continuing to wait for a larger reward. In addition, we will also assess how reward probability affects delay discounting in this task. The proposed methodology produces significant challenges to quantitative descriptions of behavior and a new framework is offered to predict behavior. Unlike discrete trials procedures, reward rate will vary with performance (fire rapidly with little damage per shot vs. fire slowly with a lot of damage per shot). We hope to expand models of delay discounting to describe real- time interaction with the environment. PUBLIC HEALTH RELEVANCE: The proposed research will help us to understand when people will behave impulsively and when they will not. A general tendency toward impulsive decision-making has been correlated with smoking, substance abuse, pathological gambling, and engaging in HIV risk-related behavior. Understanding the reasons why people make impulsive choices may inform therapeutic and educational interventions to address those socially significant behavior problems.

Public health relevance
Project Narrative The proposed research will help us to understand when people will behave impulsively and when they will not. A general tendency toward impulsive decision-making has been correlated with smoking, substance abuse, pathological gambling, and engaging in HIV risk-related behavior. Understanding the reasons why people make impulsive choices may inform therapeutic and educational interventions to address those socially significant behavior problems.